The 3E Study: Economic and Educational Contributions to Emerging Adult Cardiometabolic Health

PROJECT SUMMARY/ABSTRACT
Adverse Childhood Experiences (ACEs) may contribute to inequities in cardiometabolic health
disproportionately experienced by Latinx emerging adults. With the increased use of ACE measures in health
research, there is a need to consider how well the measures work in diverse populations and whether ACEs
categories need to be expanded to include community-level adversity. First, although existing ACE measures
have been used to understand how adversity early in life impacts the adoption of risky health behaviors and
long-term health, the original measures were developed with a population that had health insurance and was
largely white and well-educated; they do not necessarily reflect the diversity of adverse childhood experiences
that may be disproportionately experienced by some communities (e.g., immigration-related traumas,
policing-related traumas). More work needs to be done to understand how applicable they are to more diverse
populations. Second, Dr. Felitti’s original ACEs measures, typically referred to as “conventional ACEs,” were
focused on household-level adversity (psychological, physical or sexual abuse; domestic violence against the
mother; or living with household members who were substance abusers, mentally ill or suicidal, or ever
imprisoned). Increasingly, researchers recognize that experiences outside the home also shape the lives of
children and influence health and health behavior, especially for people from minoritized racial/ethnic groups
and/or those living in poverty, and are calling for expanded ACE measures that address interpersonal and
community-level adversity. Expanded ACE measures can include experiences of poverty, racism,
discrimination, bullying, immigration-specific adversity, and community violence. In addition to expanding ACEs
to include community level adversity, it may be useful to consider the framework of resilience or positive
childhood experiences. Narayan et al. developed the Benevolent Childhood Experiences (BCE) scale that
focuses on promotive factors. Measures include positive experience with parents, peers, teachers, and
extended social networks, a supportive environment, and a predictable routine.
The objectives of this diversity supplement are 1) to develop an ACE scale specific to community level
stressors (poverty, racism, discrimination, bullying, immigration specific adversity and community violence), 2)
to quantify ACEs and BCEs in the 3E study’s cohort of diverse emerging adults, and 3) to use qualitative
methods to document and contextualize how adversity impacts cardiometabolic behaviors (diet, physical
activity, sleep, and smoking) and cardiometabolic health (weight and blood pressure).
The evidence generated from this work could inform future community-level interventions targeting
determinants of cardiometabolic health and will position the candidate to have an impactful career as an
independent researcher investigating the impact of community level adverse childhood experiences on
cardiometabolic health in diverse populations.

Public health relevance
PROJECT NARRATIVE Adverse Childhood Experiences (ACEs) may contribute to cardiometabolic health inequities disproportionately experienced among Latinx emerging adults, but current measures may inadequately account for community-level adversity. The proposed study will develop a culturally-relevant ACEs scale that includes contextual stressors for inclusion in the parent study, and then conduct in-depth interviews to qualitatively identify processes by which community level ACEs influence health behaviors (sleep, physical activity, diet, and smoking). The results of this work may inform future interventions to improve cardiometabolic health and reduce cardiometabolic health inequities.